Evaluating nutrition labeling policy changes in the US and Mexico.

PROJECT SUMMARY
The United States (US) and Mexico have the highest prevalence of obesity in the world. In the US, Latinxs,
who comprise the largest ethnic minority group, have disproportionately high rates of poor diet quality, obesity,
and diet-related health outcomes. Food labeling is a low-cost, wide-reaching intervention for communicating
nutrition information to consumers so they can make more informed, healthier food choices. Between 2020 and
2021, the US is changing the Nutrition Facts Label (NFL) on pre-packaged foods, which will increase the
visibility of calorie amounts and serving sizes while introducing information on added sugar. NFLs have been
criticized, however, for their complexity and location on the back of packaging. Front-of-package (FOP)
nutrition labels provide more visible and simplified information on the nutritional value of foods, enabling
consumers to easily compare options at the point of product selection. Between 2020 and 2021, Mexico will
implement mandatory FOP warnings in the form of prominent “stop signs” on packaged foods that are high in
calories, sodium, sugar, saturated fat, or trans fats, as well as products with added caffeine or non-caloric
sweeteners. To evaluate the relative effectiveness of these new US and Mexican policies, the current proposal
leverages data from the International Food Policy Study (IFPS), which has annually surveyed approximately
4000 US and 4000 Mexican adults since 2018. Funding for Mexico ends in 2020, though funding is secured for
the US through 2024. Mexicans and US Latinxs with lower educational attainment – key groups with
disproportionately high obesity rates and for whom the FOP warnings may be most effective – have been
under-represented in IFPS surveys. The proposed study will continue annual surveys of Mexican consumers
through 2024 (n=4000/year) while providing an oversample of US Mexican Americans (MAs; n=2000/year)
who comprise approximately two-thirds of all US Latinxs. We will recruit additional samples of Mexicans
(n=1500/year) and MAs (n=1500/year) with lower education. This pre/post study will compare within- and
between-countries over time to address two aims. Aim 1 will evaluate the impact of the mandatory FOP
warnings in Mexico relative to NFL changes in the US. We hypothesize that increases in awareness/use of
nutrition labels, nutrition knowledge, and healthy dietary behaviors will be greater in Mexico than in the US,
including US MAs. Aim 2 will evaluate disparities in the effects of these nutrition labeling policies. We
hypothesize that awareness and use of FOP warnings, nutrition knowledge, and healthy dietary behaviors will
increase more from pre- to post-policy among disadvantaged groups in Mexico than in the US due to the
greater prominence and simplicity of the Mexican FOP warnings. Finally, we expect that post-implementation
trends in labeling effects among disadvantaged groups will favor the Mexican over US policy. The results from
this study will inform policy development in the US and globally, as well as communication theories that guide
product labeling to promote healthy behaviors.

Public health relevance
PROJECT NARRATIVE Between 2020 and 2021, US policy changes will require increased visibility of information about calories, serving sizes and added sugars on the back or side of packaged foods. During the same time, Mexico will put “stop sign” warnings on the front of packaged foods that are high in calories, sodium, sugar, or fat, as well as on products with added caffeine or sweeteners. This study will analyze surveys of Mexicans and Americans, including Mexican Americans, to evaluate labeling policy effects on nutrition knowledge and healthy eating, including which policy is most effective for people with limited resources.